TEAM-UP: Tobacco treatment navigators uniting with primary care

PROJECT SUMMARY
Tobacco use disorder is the deadliest substance use disorder accounting for nearly half a million premature
deaths in the United States each year. Primary care clinics have the potential to reach the majority of the
population with tobacco cessation assistance in the context of ongoing care, but uptake of evidence-based
strategies is poor. Team-based and electronic health record-supported approaches to promote tobacco
assessment and referral to cessation services (e.g. Quitlines) have been successful, but were significantly
disrupted by the sequelae of COVID-19. Population outreach approaches using navigators and technologies
such as patient portals have been effective in facilitating patient access to and engagement with care services
and can improve health outcomes. Important gaps in understanding which outreach approaches effectively
reach and engage low-income primary care patients with tobacco cessation support remain. We propose that
using an outreach strategy focused on patients who were not assisted during a recent primary care visit will
greatly improve the delivery of tobacco cessation support to patients. We examine two outreach strategies: a
predominately person-based outreach navigator (ON) vs. a technology-based interactive patient portal (IPP).
Patients that are not offered assistance during a primary care visit will be randomized into 3 groups: ON vs.
IPP vs. usual care / no outreach group (NOC). Both implementation strategies will use an evidence-based
approach to communicate the importance of cessation counseling and tobacco cessation medications for an
effective quit strategy, offer patient choice among options, and facilitate referrals to tobacco cessation
counseling and orders for medications using EHR tools. This study aims to:
1. Implement a tobacco treatment outreach intervention with ON vs. IPP vs. NOC to compare rates and
correlates of receipt of cessation counseling and tobacco cessation medication orders.
2. Evaluate the effectiveness of ON vs. IPP vs. NOC on tobacco quit status.
3. Estimate and compare the costs and cost-effectiveness of ON vs. IPP.
These aims will be accomplished with a three-arm randomized trial with 6000 patients (randomization ratio of
1:1:1) from 10 community-based clinics. EHR data and patient surveys will be used to assess the effect of the
ON vs. IPP vs. NOC on patient reach and effectiveness outcomes and whether the approaches work equitably
across important subgroups of patients. We will also assess the cost to implement and conduct each outreach
approach and conduct cost-effectiveness analyses. For each Aim, qualitative methods will complement the
hypothesis testing analyses to better inform observed differences in outcomes of the approaches. This study is
well aligned with NIDA priorities and fills a critical knowledge gap of identifying effective and scalable strategies
to improve tobacco cessation assistance among low-income primary care patients.

Public health relevance
PROJECT NARRATIVE To improve the delivery of tobacco cessation support to primary care patients, we unite the efforts of primary care clinics with outreach navigation to offer tobacco cessation assistance to individuals who use tobacco. We test two outreach strategies: 1) a person- vs. a technology-focused approach; both follow the same protocol to offer and connect patients to the tobacco cessation support services they choose, but differ in mode of delivery. We compare the two strategies on outcomes of whether patients receive tobacco cessation counseling and medications and whether 6 months later they report quitting tobacco; we also evaluate the cost effectiveness of the approaches.